Sugar Utilization by Microglia in Alzheimer's Disease

Project Summary: Alzheimer’s disease (AD) is a progressive dementia effecting 1 in 8 Americans over the age of 65. Currently no cure or effective treatment is available for AD. Recently, the field has recognized the role of microglia in the pathogenesis and progression of AD. Triggering receptor expressed on myeloid cells 2 (Trem2) is a major microglial receptor that when lost results in an aberrant microglial response to amyloid β (Aβ) plaques. We have demonstrated that in the absence of Trem2 microglia fail to cluster around plaques resulting in the plaques being more neurotoxic. We have also found that the primary function of Trem2 in microglia is to boost and sustain microglial metabolism in the setting of chronic stimulation such as the response to Aβ plaques. Finally, we have preliminary evidence that suggests that in response to Aβ plaques microglia become more dependent upon glucose metabolism and less dependent on uptake of locally produced fructose. In contrast Trem2-deficient microglia do not undergo this transition. In this proposal we will further explore the role of microglial sugar metabolism and develop new resources that will be necessary to pursue future research.

Public health relevance
Public Health Relevance/Narrative: Alzheimer’s disease is one of the most prevalent and impactful diseases in the United States and throughout the developed world and currently no treatments or therapeutics that slow or stop Alzheimer’s disease are available. This project seeks to determine the role of sugar metabolism in microglia, the brain’s innate immune cell. The proposed work is expected to result in new information that can inform the development of new therapeutic strategies or treatments for Alzheimer’s disease.